Many Hosts of Mycobacteria 9 Conference

ABSTRACT
The 9th Many Hosts of Mycobacteria (MHM9) meeting will be held at The Ohio State University (OSU) in
Columbus, Ohio March 8-10, 2022. This meeting is co-organized by Rich Robinson (OSU), Luanne-Hall Stoodley
(OSU), Matthew Anderson (OSU), Michelle Larsen (Albert Einstein College of Medicine), Fred Quinn (University
of Georgia), Liliana Salvador (University of Georgia) and John Spencer (Colorado State University). The purpose
of the meeting series is to bring together basic researchers, clinicians, and human and animal health researchers
that study mycobacterial diseases/hosts. The previous eight MHM meetings have been held at the National
Animal Disease Center in Ames, IA (2007), Gettysburg, PA (2008), the historic former leprosy sanatorium in
Carville, LA (2009), Lowry Zoo in Tampa, FL (2011), Bethesda, MD (2012), Tulane National Primate Research
Center, Covington, LA (2015), Colorado State University, Fort Collins, CO (2017), and Albert Einstein College of
Medicine, The Bronx, NY (2019). These meetings are small (~90 attendees) and have open registration. A
workshop format is used for the meetings to foster open and interactive discussion. The diverse perspectives
are exemplified by inclusion of fourteen models (mouse, guinea pig, rabbit, badger, possum, ferret, mongoose,
armadillo, fish, deer, cow, elephant, monkeys and humans) and both experimental and natural infections
(Tuberculosis from M. bovis and M. tuberculosis; Leprosy from M. leprae; Johne’s Disease from M. avium
paratuberculosis; general mycobacterial infections from M. ulcerans and nontuberculous mycobacteria). With an
overarching theme of mycobacterial diseases and hosts, each meeting has had a specific focus: ‘Many Hosts of
Mycobacteria’ (MHM1, 2007); ‘Immunopathology’ (MHM2, 2008); ‘Comparative Mycobacteriology’ (MHM3,
2009); Biomarkers (MHM4, 2011); Translational Science (MHM5, 2012); ‘Host Specificity and Disease
Dynamics’ (MHM6, 2015), ‘Bringing Science into the Community’ (MHM7), and ‘Back to the Future’ (MHM8).
The theme of the MHM9 meeting will be ‘Confounders of Mycobacterial Disease’ as there are multiple
confounders which can (and often do) drive the transmission of mycobacterial diseases and impact
mycobacterial disease surveillance, treatment and outcomes. We target inclusion of young investigators as
speakers and moderators for these meetings to foster discussion of new ideas and allow for development of
collaboration between research groups that do not typically interact with each other, and this year will focus on
underrepresented groups such as Native Americans.

Public health relevance
PROJECT NARRATIVE The Many Hosts of Mycobacteria meeting series uses a small (~90 attendees) workshop-style format with open registration that targets inclusion of young investigators as speakers. The meeting purpose is to bring together researchers and human and animal clinicians that work on a wide range of mycobacterial diseases.